DEVELOPING RHESUS MODEL OF PROINFLAMMATORY PROCESSES IN DEPRESSION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The goal of the project is to determine if naturally-occurring depressive-like behavior in monkeys is related to concentrations of proinflammatory cytokines in blood, and if depressive-like behavior can be induced short-term by administration of cytokines.